IUGR induced epigenetic modifications to the PPARγ? gene

DESCRIPTION (provided by applicant): Poor growth of the fetus in utero, or intrauterine growth restriction (IUGR), increases visceral obesity and associated co-morbidities in humans. Visceral obesity is associated with increased expression of the PPARγ gene. Expression of genes is controlled by epigenetics and one epigenetic modifying enzyme is Setd8. We showed in other tissue types that Setd8 affects PPARγ epigenetics in association with changes in PPARγ expression. However, it is unknown if 1) this occurs in visceral adipose tissue, 2) if it is affected by IUGR, or 3) if the PPARγ -setd8 and PPARγ expression are causatively related. This proposal uses a rat model of IUGR to understand the relationship between IUGR and PPARγ -Setd8-epigentics in the adipose tissue. We will test two hypotheses in this proposal. First, that increased Setd8 levels in male IUGR rat visceral adipose tissue are associated with increased levels of an epigenetic modification made by Setd8, H4K20Me, of the PPARγ gene. For this we will use a rat model of IUGR. Second, we will test the hypothesis that IUGR increases lipid uptake by primary visceral adipose culture while knockdown of Setd8 or PPARγ reduces lipid uptake, PPARγ2 expression and H4K20Me of the PPARγ gene. To test this, we will use primary adipose cell culture. This work is significant to public health because understanding one molecular mechanism by which IUGR induces epigenetic modifications to PPARγ in IUGR visceral adipose tissue will provide insight into the root causes of visceral obesity in IUGR. Understanding these mechanisms will lead to the ability to develop interventions that can target specific epigenetic changes, with the potential to improve the metabolic health of formally growth restricted individuals.

Public health relevance
The development of visceral obesity and associated co-morbidities in infants that fail to grow properly in utero, involves epigenetic modifications to PPARγ . Understanding how these epigenetic modifications are made, and influenced by fetal growth restriction, will lead to the ability to develop interventions that can specifically target these epigenetic changes, with the potential to improve the metabolic health of formally growth restricted individuals.